Culturally Adapting Spiritually and Technologically Informed Interventions to Reduce Alcohol-Related Health Disparities among Latinx Young Adults

PROJECT SUMMARY
This is a K01 award application for Dr. Hang Hai, a young investigator with a strong commitment to
reducing alcohol-related health inequities among people of color (long-term goal). This K01 award will provide
mentorship and research experience to advance her intermediate goal of becoming an independent NIAAA
investigator with expertise in developing scalable, culturally appropriate, technology-enhanced, spirituality-
integrated alcohol interventions for Latinx young adults (YAs). This award will facilitate Dr. Hai’s achievement of
the following training goals (TG): to develop critical knowledge and skills in 1) the development of mobile health
alcohol interventions, 2) qualitative research methods for cultural adaptation of alcohol interventions for Latinx
populations, 3) the role of spirituality in alcohol use disorder (AUD) recovery and spirituality-integrated alcohol
interventions, including 12-step programs, and 4) alcohol misuse among YAs. Dr. Hai has assembled a
multidisciplinary mentorship team with internationally recognized experts in each training area. She will achieve
her training goals through mentored training and research, directed readings, formal coursework, and training
institutes/programs. To acquire hands-on research experience in all training areas, Dr. Hai proposes an
innovative, mentored research study focused on developing a smartphone-app-based intervention for Latinx YAs
with AUD. Latinx YAs are a large and rapidly growing population particularly vulnerable to alcohol-related
disparities. Alcoholics Anonymous (AA) has the potential to help lift this public health burden but is underused
by Latinx YAs. 12-Step Facilitation (TSF), an evidence-based, professionally delivered, spirituality-integrated
intervention specifically designed to promote AA engagement, is a promising tool to help leverage AA. However,
literature and preliminary data show that adaptation is needed to ensure TSF is effective, accessible, scalable,
and culturally appropriate for Latinx YAs. In response to this need, the proposed research aims to adapt TSF in
three critical ways: 1) to increase TSF’s socio-cultural appropriateness for Latinx YAs, we will add an intervention
component to address the link between drinking problems and minority status-related factors, such as ethnic
discrimination and acculturation stress; 2) update TSF’s spirituality-related language and content to better
resonate with Latinx YAs; and 3) adapt TSF into a smartphone-app-based intervention (eTSF) to maximize
intervention accessibility and scalability. The proposed research aligns with the NIH-wide strategic plan’s aim to
“improve minority health and reduce health disparities” and NIAAA’s strategic plan Objective 4a to “Improve
existing behavioral treatments for alcohol use disorder” through “use[ing] electronic health technologies including
mobile devices.” This study will lay the groundwork for testing a fully powered randomized trial (R01 submission
in Year 5) and expanding eTSF’s scope to include other minoritized populations in the future.

Public health relevance
PROJECT NARRATIVE Latinx young adults are acutely vulnerable to alcohol-related health disparities, and even more worrisome, this population demonstrates extremely low engagement rates in alcohol use disorder recovery support. Hence there is a critical need for the development of scalable, culturally appropriate, accessible, and effective alcohol interventions for this large and rapidly growing at-risk population. This study aims to address this need by socio- culturally adapting an existing underutilized evidence-based intervention and making it broadly available through a smartphone app.